Long Term Effects of Breast Cancer Therapy on Cardiac Remodeling and Function

Project Summary
Highly effective breast cancer therapies, including anthracyclines and HER2+ targeted therapies are used widely
and have led to important oncologic survival gains. However, these agents --- doxorubicin, trastuzumab
(Herceptin®), and pertuzumab (Perjeta®) --- carry an established short-term cardiotoxicity (CTX) risk, within 1-
2 years after initiation of cancer therapy. Doxorubicin-induced CTX, defined primarily by left ventricular ejection
fraction (LVEF) declines, cardiomyopathy, and heart failure (HF), occurs in 10-15% of patients at dosages of
240mg/m2. HER2+ targeted therapies such as trastuzumab and pertuzumab result in LVEF declines in 9-18%
of treated patients. Doxorubicin and HER2+ targeted therapies in combination are associated with LVEF declines
in up to 33% of individuals, and severe, symptomatic HF in 2-4%. The development of CTX in the short term
results in dose interruptions, treatment delays, and worse oncologic outcomes. However, the long-term
consequences of these therapies are poorly understood, as prior studies report inconsistent findings and are
limited by external validity. Our application, directly responsive to NIH PA 19-111, comprehensively defines the
incidence and severity of cancer-treatment related CTX in the long-term, with a focus on late effects.
In this R21, we leverage the existent infrastructure within the prospective, longitudinal Penn CCT cohort study
(R01 HL 118018, 2014-2020), which enrolled 611 breast cancer patients. We will define the effects of
anthracyclines and/or HER2+ targeted cancer therapies in the long-term, over a maximum follow-up time of 10
years, through a detailed and comprehensive evaluation of the trajectories of cardiac remodeling and function.
We focus specifically on late cardiac dysfunction, defined as the incidence at ≥5 years’ of followup in the 318
CCT participants with ≥5 years’ of followup. We also focus on cardiac recovery, defined as: 1) partial (LVEF
increase >5% absolute points and >50%) or 2) full (LVEF increase to >55%). In Aim 1, we will comprehensively
determine the late changes in cardiac remodeling and function in women with breast cancer receiving
anthracyclines and/or HER2+ targeted therapy. In Aim 2, we will determine the clinical predictors of late LVEF
declines and recovery. In Aim 3, we will determine the echocardiographic predictors of late LVEF declines and
recovery. By addressing each of these Specific Aims, we will provide insight into the development of effective
cardiac function monitoring and treatment strategies in this high CV risk population. Breast cancer therapy CTX
is a significant problem, and decreasing this public health burden is a high priority in both cardiology and
oncology. In this R21, we will build upon the early insights and unique resources of R01 HL118018 to gain new
knowledge into late CV effects.

Public health relevance
Project Narrative Doxorubicin and HER2+ targeted therapies, including trastuzumab and pertuzumab, are highly effective in the treatment of various malignancies but, in certain patients, this treatment can result in significant adverse effects on the heart. Our proposed study will use an existent infrastructure to understand the late cardiotoxic effects of breast cancer therapy. We will define the clinical and function predictors of left ventricular ejection fraction declines and recovery in the long-term.